MARKERS FOR PROGRESSION TO CHRONIC KIDNEY DISEASE - ROLE OF KALLIKREIN

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Demonstrate that decreased urinary kallikrein activity is associated with incomplete recovery from acute kidney injury